Deciphering mechanisms of vascular disease with cell and process specific ligands

Project Summary / Abstract
The primary mechanism responsible for many acute vascular disorders, including in-stent restenosis, vein graft
disease, and cardiac allograft arteriopathy, is pathological vascular smooth muscle cell (VSMC) activation.
VSMC activation leads to neointimal formation and re-occlusion of injured blood vessels. Strategies to prevent
abnormal VSMC remodeling, such as cell growth inhibitors used in drug eluting stents, have the undesired
effect of impairing re-endothelialization. This attenuation of endothelial healing increases the risk of
neoatherosclerosis and late stent thrombosis. In order to prevent pathological VSMC growth, but not re-
endothelialization, there is a critical need to identify cell-surface proteins that may can be targeted by agents to
distinguish between VSMCs and endothelial cells (ECs) and modulate cellular processes utilized by VSMCs
during pathological remodeling that do not affect endothelium healing. The objective of this proposal is to utilize
VSMC-targeting aptamers that specifically modulate VSMC migration, proliferation and apoptosis to define 1)
define the cell-surface proteins and mechanism of action by which VSMC-targeting aptamers modulate VSMC
but not EC processes; and 2) determine the impact of these cell- and process-specific ligands on neointimal
formation and re-endothelialization following acute vascular injury. We recently identified a VSMC-specific anti-
migratory aptamer that prevents VSMC migration with no effect on EC migration. We determined that the
VSMC anti-migratory aptamer operates by antagonizing PDGFR-β activation, but has no effect on PDGF-BB-
mediated VSMC proliferation. These data suggest the novel concept that PDGFR-β migration and proliferation
signaling may be dissociated. We have now identified two additional VSMC-targeting aptamers that modulate
VSMC, but not EC, proliferation and apoptosis through unknown mechanisms originating at the cell surface.
We will test the overall hypothesis that VSMC cell surface proteins and signaling pathways necessary for
migration, proliferation and apoptosis following acute vascular injury may be cell-specifically modulated to
prevent neointimal formation without altering EC re-endothelialization. In Aim 1, we will define the mechanism
by which VSMC PDGFR-β dependent migration is dissociated from PDGFR-β dependent proliferation and may
be inhibited to prevent neointimal formation without interfering with re-endothelialization. Aim 2 will identify the
cell-surface protein, using a novel application of a whole-genome CRISPR library, and define the mechanisms
where VSMC proliferation may be specifically inhibited in VSMCs to prevent neointimal formation without
impacting re-endothelialization. Aim 3 will determine the mechanism and cell surface-proteins by which VSMC
apoptosis may be induced to limit neointimal formation while preserving re-endothelialization. Completion of
this study will result in a mechanistic understanding of modulating VSMC migration, proliferation and apoptosis
towards preventing neointimal formation and preserving re-endothelialization, with applicability to a number of
acute vascular diseases.

Public health relevance
Project Narrative / Public Health Relevance Statement Common treatments for vascular disorders include revascularization procedures to restore blood flow (e.g., stenting, bypass surgery), yet these procedures also damage healthy tissue within vessel, leading to re- narrowing. Our goal is to define the sequence of events by which different cells within the vessel wall respond to injury using novel tools that we have discovered that target one cell type but not another. Data from this study will serve as a platform to develop safer and more efficacious therapies that mitigate the risk of complications associated with revascularization procedures.